The Physiology of the Weight Reduced State Data Coordinating Center

Funds for this administrative supplement are requested to support additional effort for investigators
(Drs. Belle and Jakicic), data systems and data management, project coordination, sIRB and travel. The
RFA called for 2 clinical centers, but one of the clinical centers (CUIMC) also included the New York State
Psychiatric Institute where assessments were to be performed and the other site is a combination of 3
sites (Drexel University, the University of Pennsylvania, and Tufts University). Though the New York
State Psychiatric Institute may not be involved moving forward, the additional sites resulted in, and will
continue to require, the need for more administrative oversight by Dr. Belle, more systems
development and maintenance, more coordinator time, and greater than anticipated sIRB costs.
Additionally, the MPI from Drexel University has moved to Dartmouth College, also expanding
administrative and sIRB costs requiring increased efforts for Dr. Belle and a project coordinator. Dr.
Jakicic, a co-Investigator, became the primary developer of the intervention and continues work with
the interventionists to monitor intervention delivery so, as a result, he spends greater than anticipated
effort preparing documents for, and working with, the interventionists. Dr. Jakicic also leads the weight
adjudication subcommittee, which was not envisioned when applying for the project. Finally, the
extensive data collection approved by the Steering Committee has resulted in substantially more data
systems development/maintenance and data management effort to optimize data completeness and
accuracy.

Public health relevance
The POWERS consortium protocol includes substantially more data collection, from more data streams, than was envisioned in our proposal. Dr. Jakicic is more involved with the intervention, interventionists, and subcommittees than originally envisioned. With one of the Clinical Centers including multiple institutions and numerous protocol amendments, the data management and administrative effort is more than originally envisioned and the costs for the single IRB are higher than anticipated. This results in the need for additional effort provided by investigators and other DCC personnel.